Characterization and connectomics of striatal interneurons

Project Summary/Abstract
The striatum is the main input structure of the basal ganglia, a system that is crucial not only for voluntary
motor control, but also for reinforcement-mediated learning and higher cognitive functions. The importance of
the striatum is illustrated by the severe disabilities associated with numerous neurological and neuropsy-
chiatric conditions that affect this brain structure.
The recent introduction of methods for targeting and manipulating genetically and physiologically
defined cell types is currently revolutionizing our understanding of the neostriatum. Our preliminary studies,
together with recent research demonstrate that the classically known cell types represent less than a third of
the interneuron classes in the striatum, and reveal an intricate and precisely organized circuitry of these
neurons. The prosed study will test 4 novel hypotheses which were formulated on the basis of preliminary
data and capture functionally important principles of organization of the network of striatal interneurons.
First, we will investigate the connectivity of genetically identified interneurons and test the hypotheses that
their connectivity is highly cell type specific and structured to form at least 2 separate interneuron sub-
networks within the neostriatum. Second, building on our previous research and novel preliminary data we
hypothesize that cholinergic interneurons (CINs), which traditionally have been thought of as
neuromodulatory elements, participate in a fast bi-directional synaptic network with multiple GABAergic
interneurons utilizing nicotinic excitatory connections. Importantly, our preliminary data also suggest the
existence of a novel source of nicotinic excitation from the brainstem that appears to selectively target a distinct
subset of GABAergic interneurons. Third, we will test the hypothesis that a subset of interneurons are
hierarchically organized in the sense that one or more classes of interneurons exist which are specialized to
control the activity of other interneurons. These interneuron-specific interneurons are of great interest because
their impact may be widely distributed and disproportionally amplified via hierarchical control of other
interneurons. Finally, based on preliminary data we hypothesize that a class of novel GABAergic interneurons
are essential for normal goal-directed behavior, and we will explore the mechanism of action of these neurons
using in vivo electrophysiological and Ca2+-imaging methods. These experiments will yield important new
insights into the functioning of the striatum and may help to identify new cellular substrates for therapeutic
interventions in a variety of neurological and neuropsychiatric disorders.

Public health relevance
Project Narrative: This project seeks to extend our previous findings with respect to specific and selective inputs and outputs of novel GABAergic interneurons of the neostriatum, a part of the brain that is essential for many functions including normal voluntary motor behavior, reward prediction error, and several types of learning. We will use state-of-the art electrophysiological, molecular and genetic techniques to be able to identify and manipulate striatal GABAergic interneurons with optical or pharmacological stimulation. We will use ex vivo whole cell, cell attached and paired recordings, and in vivo calcium imaging or tetrode recordings of identified GABAergic interneurons in mice performing an operant task to determine the intrastriatal microcircuitry and behavioral functions of the interneurons.